10-ETHYL-10-DEAZA-AMINOPTERIN AND CHEMOTHERAPY FOR NON-SMALL CELL LUNG CANCER

The objectives of this protocol are to compare the combination of 10-Ethyl-10- Deaza-Aminopterin (10-EdAM), mitomycin and vinblastin (EMV) with the combination of mitomycin and vinblastine (MV) in the treatment of patients with advanced Non-Small Cell Lung Cancer and to demonstrate that the two regimens are acceptable in terms of toxicity and to compare their relative toxicity. This is an open-label, multicenter, randomized trial.